The San Diego Implementation Science Hub to Advance HIV Research and Impact Using Implementation Science and Practice

Project Summary/Abstract Section
The San Diego Implementation Science Hub (SD IS Hub) applies implementation science (IS) principles to support the objectives of the NIH Ending the HIV Epidemic (EHE) initiative. While effective interventions for HIV exist, their broad and sustained implementation remains a challenge. IS provides structured methodologies to enhance the adoption, scale, and long-term use of these interventions. Since 2019, our SD IS Hub has delivered technical consultation and support to 29 EHE projects, contributing to successful completions, publications, and the development of new research efforts. Additionally, the Hub has participated in national coordination initiatives, such as the Implementation Science Coordination Initiative (ISCI), helping to refine shared metrics and deliver training to the national audience. Our team brings extensive experience in both HIV and implementation science and collaborates with key partners in health services and policy to ensure that support resources are practical, scalable, and aligned with real-world needs. This proposal seeks to expand and enhance our offerings through four core aims: (1) Project-Specific IS Coaching: Provide tailored coaching based on project stage and technical requirements, incorporating structured support and progress monitoring using outcome indicators. (2) Implementer Learning Core (ILC): Co-develop and deliver targeted technical assistance with healthcare implementers and academic users, building broader capacity for effective IS application in HIV-related research and practice. (3) EHE Dissemination Core: Translate project outcomes into usable tools for partners across sectors and coordinate with the Coordination, Consultation, and Data Management Center (CCDMC) and other Regional Hubs to promote alignment and efficiency. (4) Evaluation and Outcome Tracking: Apply the Translational Science Benefits (TSB) Model to guide structured evaluations of project and Hub-level outcomes, including profile generation and visualization tools that inform future implementation strategies. Our proposal introduces innovations such as AI-assisted data tracking, structured outcome evaluations, and practical dissemination resources. These tools are designed to benefit researchers and health service partners alike, extending the reach and impact of HIV-related science. The SD IS Hub's operational approach and expanded service model will enhance the NIH EHE portfolio and contribute to advancing the field of implementation science in a practical, efficient, and scalable manner.

Public health relevance
Public Health Relevance Section The San Diego Implementation Science (SD IS) Hub offers a structured framework to integrate implementation science (IS) methodologies into research and program efforts aimed at reducing the incidence of HIV/AIDS and associated conditions. Building on consistent funding and operational experience since 2019, the SD IS Hub is positioned to expand its support infrastructure to further improve implementation outcomes within the NIH Ending the HIV Epidemic (EHE) research portfolio. This project will strengthen and extend the capacity of the SD IS Hub by offering individualized IS consultation and technical assistance to federally funded EHE projects and contribute to the synthesis and translation of research findings into generalizable, operational guidance and participate in training activities designed to build IS proficiency among researchers and practitioners.